Peri-procedural transmural electrophysiological imaging of scar-related ventricular tachycardia

Project Summary
Ventricular tachycardia (VT) is an important cause of mortality and morbidity in patients with heart diseases.
The majority of life-threatening VT episodes are caused by an electrical "short circuit", formed by a narrow
channel of surviving tissue inside myocardial scar. An important treatment for scar-related VT is to target and
destroy these culprit slow-conducting channels. Effective ablation requires the ability to delineate the
morphology of the circuit in order to identify the slow-conducting channels. Unfortunately, with conventional
catheter mapping, up to 90% of the VT circuits are too short-lived to be mapped. For the 10% “mappable” VTs,
their data are available only during ablation and limited to one ventricular surface. This inadequacy of
functional VT data largely limits our current knowledge about scar-related VT and ablation strategies, and
reduces the ability of clinicians to identify ablation targets and assess ablation outcome. The goal of this
proposal is to develop a novel technique to provide pre- and post-ablation functional VT data – integrated with
LGE-MRI scar data in 3D – to improve VT ablation with pre-procedural identification of ablation targets and
post-procedural mechanistic elucidation of ablation failure. It builds on the rapidly increasing clinical interest in
electrocardiographic imaging (ECGi), an emerging technique that obtains cardiac electrical activity through
inverse reconstructions from body-surface ECGs. Its specific objectives include:
1) To develop and validate a peri-procedural ECGi for mapping scar-related VT circuits.
2) To integrate LGE-MRI scar into ECGi for improved electroanatomical investigations of VT circuits.
3) To perform clinical evaluation of pre-ablation and post-ablation MRI-ECGi of scar-related VT.
These investigations will be carried out on a prospective cohort of 40 patients with VT due to previous
infarction. This research builds on our previously established technical foundation for transmural ECGi and
promising preliminary data generated under the support of our exploratory NIH grant. It is further supported by
previous technical and clinical advances in each of the subcontractors' lab, including camera-based torso
modeling (Siemens), intramural mapping and ablation (NSHA), and LGE-MRI scar imaging in VT (UPenn). The
outcome of this research will generate new knowledge about the electroanatomical mechanism of scar-related
VT and the mechanism behind ablation failure. It will enable pre- and post-procedural mapping of 3D functional
circuits of all inducible VTs, improving the ability of clinicians to identify ablation targets and assess ablation
outcome. Finally, it will timely deliver the next generation of ECGi techniques to further our general technical
capability for safer and more efficient cardiac electrophysiological studies in a broader variety of heart
diseases.

Public health relevance
Project Narrative Catheter ablation treats ventricular arrhythmia by destroying the tissue responsible for the arrhythmia. Effective ablation requires imaging guidance to visualize the arrhythmia circuit in relation to the surrounding scar tissue in 3D, which is currently not possible. This research will develop a novel technique for pre-ablation and post- ablation imaging of the arrhythmia circuit integrated with the 3D scar tissue to improve identification of ablation targets and assessment of ablation outcome.